Programmable control over histone acetylation at human regulatory elements using precision epigenome editing

PROJECT SUMMARY/ABSTRACT
Dysregulated gene expression contributes to nearly every human disease. The level at which we understand the
inherent complexity of gene regulation ultimately dictates our ability to link and/or manipulate biomolecular
changes and pathology. Beyond their function as a structural substrate, histone proteins play key roles in gene
expression by selectively gating access to DNA and thereby guiding when and how transcriptional machinery
engages the human genome. Histone-based gene regulatory control largely stems from post-translational
modifications (PTMs) to histone proteins themselves. One type of PTM, histone lysine acetylation, is particularly
critical for gene regulation and human health, because overall acetylation levels tightly correlate with genomic
activity and gene expression, and inappropriate histone acetylation patterns are linked to diverse human
diseases. In fact, small molecules that globally change histone acetylation across the human genome have
emerged as important therapeutics. However, in many patients these drugs can be ineffective and/or can result
in toxic side effects. Furthermore, small molecules that globally alter histone acetylation patterns cannot be used
to dissect how changes at specific locations in the human genome drive disease pathology. Robust tools that
enable precise and targeted control over endogenous histone acetylation are urgently needed, because these
technologies could illuminate the function(s) that this complex epigenomic signature plays within the human
genome and open the door to new sophisticated epigenetic therapies.
In this project, we will fulfill this urgent need by building synthetic and precisely targetable biomolecules that
mimic the spectrum of activities displayed by natural human histone acetyltransferases (HATs) and histone
deacetylases (HDACs) (Aim 1). Specifically, we will combine the programmability of the nuclease null
CRISPR/Cas9 (dCas9) scaffold with different classes of human HATs/HDACs and we will use these technologies
to probe the selectivity of different HATs/HDACs in vitro and within native human chromatin. We will integrate
our results with epigenomic profiling data to define how epigenetic marks, nucleosome occupancy, and cis
regulatory element proximity influence the effects of histone acetylation at human enhancers and promoters. We
will also use mass spectrometry, dCas9-based transcriptional activators and HATs, and genome-scale knockout
screening to define the proteins/protein complexes that support histone acetylation-based gene activation (Aim
2). Finally, we will establish the impact of precisely targeted histone acetylation/deacetylation on enhancer
activity and enhancer-promoter interactions (Aim 3). Experiments will be conducted at testbed human loci that
have broad significance to human health and mechanistic epigenetics, and that will serve as proof-of-principle
for interrogating virtually any regulatory element or locus in the human genome in future efforts. To accomplish
the aims of this project, we have assembled an experienced team with synergistic expertise in CRISPR/Cas-
based epigenome editing, histone PTM analysis, and functional dissection of enhancer activity.

Public health relevance
PROJECT NARRATIVE Histone acetylation and deacetylation are dynamic biological phenomena that play key roles in regulating the human genome and gene expression, which in turn is involved in almost every process underlying health and disease. Here we will create new technologies that are needed to precisely control and understand histone acetylation in living human cells. These new technologies will shed light on the diverse ways that histone acetylation coordinates the activity of the human genome and will uncover opportunities for innovative therapeutics aimed at controlling histone acetylation levels with pinpoint accuracy in human cells.